Structural studies of the OrfX-type progenitor toxin complex of botulinum neurotoxin

PROJECT SUMMARY
Botulinum neurotoxins (BoNTs) are produced by anaerobic bacteria of the genus Clostridium, which are the
causative agents of the neuroparalytic disease botulism. Nevertheless, type A and type B BoNTs (BoNT/A and
BoNT/B) have been successfully used in clinic for a variety of therapeutic and aesthetic applications, while type
E BoNT (BoNT/E) is currently in clinic trials. BoNTs are naturally produced by bacteria alongside several non-
toxic neurotoxin-associated proteins (NAPs). These NAPs are believed to engage with BoNTs in the framework
of progenitor toxin complexes (PTCs), which are high molecular weight multi-protein complexes. Accidental
BoNT poisoning mainly occurs through oral ingestion of tainted foods, and NAPs are thought to protect BoNTs
and facilitate their absorption during oral intoxication. There are two different types of PTC depending on the
neurotoxin gene clusters: the HA-type PTC has four NAPs, including non-toxic non-hemagglutinin (NTNH) and
three hemagglutinin proteins (HA17, HA33, and HA70), while the OrfX-type PTC has a different set of NAPs,
including NTNH and four proteins with unknown function (OrfX1, OrfX2, OrfX3, and P47). Extensive structural
and functional studies of the HA-type PTC, such as that of BoNT/A, demonstrate that the NAPs not only protect
the inherently fragile BoNT/A against the hostile environment of the gastrointestinal (GI) tract, but also interact
with host receptors to help BoNT/A pass through the intestinal epithelial barrier before being released into the
general circulation. However, the OrfX-type PTC remains largely uninvestigated. The goal of this proposal is to
elucidate the structure and function of the OrfX-type PTCs, including mapping the detailed protein-protein
interaction network and understanding the specificity and regulatory mechanisms underlying PTC assembly. We
will exploit a combination of cryogenic electron microscopy (cryo-EM) and X-ray crystallography, complemented
with other biochemical and biophysical methods. To comply with the CDC Select Agent regulations, we will carry
out all our studies using genetically inactivated BoNTs, and we will focus on three aims: (1) characterize the
mechanisms underlying the assembly of the OrfXs/P47 complex; (2) determine the structures of the OrfXs/P47
complex and sub-complexes; and (3) characterize the potential regulatory factors and receptors of the OrfXs/P47
complex. Together, these proposed studies will advance our structural and mechanistic understanding of the
OrfX-type BoNT complex, lay the knowledge basis for the development of new therapeutic approaches to treat
and/or prevent botulism, and potentially shed light on the pathogenesis of other OrfXs/P47-associated oral
bacterial toxins beyond BoNTs.

Public health relevance
PROJECT NARRATIVE Botulinum neurotoxins (BoNTs) are bacterial toxins causing the paralytic botulism syndrome, some of which have also been developed into effective medicines and popular cosmetics. We propose to study the structure and function of the OrfX-type progenitor toxin complex of BoNTs. This knowledge could be harnessed to help the developments of therapeutics to treat and/or prevent botulism and potentially shed light on the pathogenesis of other OrfXs/P47-associated bacterial toxins beyond BoNTs.